Building a Systems Immunopeptidomics Framework to Challenge the Current T Cell Activation Paradigm

PROJECT SUMMARY
The adaptive immune system, a cornerstone of vertebrate immunity for over 450 million years, relies heavily on
T cells to monitor and respond to peptide fragments on cell surfaces. Traditionally, T cells have been thought to
activate only in response to foreign or abnormal peptides (nonself), while viewing the myriad of normal peptides
present on cell surfaces as mere tolerogens (self). However, contrary to the prevailing dogma, our proposal
hypothesizes that the large repertoire of self-peptides presented across the entire organism—the self-
immunopeptidome—is not merely tolerated but is rather a complex entity that plays a central role in regulating T
cell responses, either enhancing or inhibiting them. This concept has profound implications across multiple fields
of medicine, including cancer immunotherapy, autoimmune disorders, infectious diseases, vaccine design,
neurodegenerative conditions, and aging-related diseases. If self-peptides are indeed central regulators of T cell
responses, this discovery would challenge existing paradigms and necessitate a complete rethinking of immune
system dynamics, which could lead to the development of novel therapeutic strategies and improve clinical
outcomes. To investigate this hypothesis, we will develop an innovative systems immunopeptidomics framework
that integrates next-generation mass spectrometry, advanced robotics, artificial intelligence, mathematical
modeling, and in vivo T cell studies. This interdisciplinary approach is unparalleled in its comprehensiveness and
potential for discovery. First, we aim to elucidate the composition of the self-immunopeptidome across different
tissues and cell types using mass spectrometry-based immunopeptidomics to discover regulatory self-peptides
at the organism level. Utilizing a novel robotic platform (IMMUNOtron), we will systematically assess the effects
of combining regulatory self-peptides and nonself-peptides on T cell activation in vitro. Machine learning
techniques will then be employed to model TCR signaling and predict how regulatory self-peptides modulate T
cell responses. In vivo studies will involve testing the impact of regulatory self-peptides on anti-tumor responses
using the NINJA mouse model, which allows for genetic manipulation of peptide presentation. Moreover, we
propose a novel application in CAR T cell therapy by incorporating regulatory self-peptides to enhance cancer
targeting while mitigating off-target effects. This innovative approach could significantly improve the efficacy and
safety of CAR-T cell treatments, making it a potential game-changer in cancer immunotherapy. The project's
novelty stems from its paradigm-shifting hypothesis and its use of cutting-edge technology and interdisciplinary
methods. By recognizing self-peptides as active participants in immune responses across tissues, this research
could pave the way for more effective and personalized medical treatments, ultimately contributing to the
establishment of a Human Immunopeptidome Project. The insights gained from this project have the potential to
redefine immune regulation, enhance our understanding of disease susceptibility and resistance, and drive the
development of tailored therapeutic strategies that leverage the regulatory power of self-peptides.

Public health relevance
PROJECT NARRATIVE The human immunopeptidome, consisting of thousands of cell surface peptides, is crucial for T cells to distinguish 'self' from 'nonself' (foreign invaders). Traditionally thought to be ignored by T cells in most tissues, we propose that self-peptides collectively influence T cell activation to fight threats. We will build an innovative systems immunopeptidomics framework to demonstrate the regulatory power of the self-immunopeptidome within the organism, which may radically shift our understanding of the immune system, lead to new therapies, and lay the foundation for a Human Immunopeptidome Project.